MULTICENTER TRIAL IN PERIODIC PARALYSIS &ASSOCIATED SODIUM CHANNEL DISORDER

This study is a randomized, double-blind placebo-controlled 2x2 crossover trial of dichlorphenamide (DCP) for preventing attacks of weakness in Periodic Paralysis (PP).